Husbandry and Management Core

Abstract
The CNPRC has maintained a breeding colony of SPF Indian-origin rhesus macaques SPF for
over nineteen years. This colony has two different levels of SPF rhesus. The population of Level
1 animals are negative for 4 persistent viruses, (SIV, SRV, STLV, and B virus). Level 2 animals
are negative for 7 persistent viruses (SIV, SRV, STLV, SFV, RRV, RhCMV, and B virus). The goal
of the Husbandry and Management Core is to expand the number of SPF Level 2 animals to meet
the needs of AIDS funds investigators investigating interaction between the host microbiome and
AIDS vaccine and therapies. The percentage of SPF2 animals will be increased while maintaining
the overall colony size. The Husbandry and Management Core will work with the Viral Testing
Core to evaluate the possible addition of 2 more viruses (Adeno-associated virus,
Lymphocryptovirus) for SPF exclusion. We will also evaluate with the Genetics Management Core
the addition of Mamu B*17 to the MHC typing panel for the colony. Finally, the Husbandry and
Management Core will systematically collect fecal microbiome and peripheral lymphoid cells from
SPF animals at their biannual physical exams to be maintained in the biorepository for use by
investigators conducting HIV/AIDS research.